DEVELOPMENTAL LUNG PHOSPHOLIPID METABOLISM

To establish an understanding of the relationship between surfactant function and metabolism in the pathophysiologic sequence of RDS, and to better characterize how exogenously administration surfactant affects the process.